Impact of Cannabis on Prefrontal Maturation

Abstract
Converging human association studies link cannabis abuse during adolescence with an increased likelihood of
developing cognitive and emotional regulation deficits later in life, many of which are refined and dependent on
prefrontal cortex (PFC) maturation during adolescence. However, the neurobiology underlying this adolescent
vulnerability remains unclear due to our limited knowledge on how adolescent cannabis exposure impacts the
maturation of neural circuits. Our long-term goal is to identify sensitive neurodevelopmental processes that are
vulnerable to repeated cannabis exposure, with emphasis on PFC neuronal circuits that undergo functional
remodeling during adolescence. Data from our recent studies revealed that a hallmark of PFC maturation is the
re-calibration of an excitatory-inhibitory (E-I) balance during adolescence that is required for sustaining proper
PFC-mediated behaviors in adulthood. Our data also indicate that it is the maturation of GABA function that
renders the PFC labile during adolescence, a developmental process that is intimately linked to the activity of
afferent transmission from the ventral hippocampus. Similarly, adolescent, but not adult, exposure to THC
impaired the maturation of PFC GABA function. This raises the exciting possibility that the PFC deficit resulting
from adolescent THC exposure is mechanistically linked to the disruption of specific inputs driving PFC
maturation. Based on our preliminary data, we will test the central hypothesis that the developing PFC GABA
circuit during adolescence is highly sensitive to the negative impact of cannabis through a ventral hippocampal
-mediated mechanism. Thus, the rationale for undertaking this research is that if PFC GABA maturation is
compromised by adolescent THC exposure, the normal facilitation of PFC inhibitory control will be arrested,
which in turn could lead to an enduring state of PFC disinhibition resulting in behavioral deficits in adulthood. We
will fill this gap in knowledge through the pursuit of 3 Specific Aims. We will use a recently developed
combustion/smoking chamber to deliver THC at 3 non-overlapping adolescent windows to establish the precise
period during which changes in PFC GABA function (Aim 1) and PFC-sensitive behaviors (Aim 2) are susceptible
to repeated THC exposure. Currently available input-specific DREADD manipulations will be used in Aim 3 to
establish whether the enduring PFC GABA deficit elicited by THC is causally linked to disruption of ventral
hippocampal-to-PFC transmission.

Public health relevance
Project Narrative The proposed research is directly relevant to public health because it will reveal key developmentally-regulated neural circuit mechanisms that render the maturation of the prefrontal cortex vulnerable to the detrimental impact of cannabis during adolescence. This goal is directly aligned with the NIDA agenda by delineating a developmental framework in which substance use disorders-associated behavioral deficits can be understood, specifically those arising during the adolescent transition to adulthood. This knowledge is expected to fully serve NIH-NIDA mission by devising timing-sensitive intervention strategies to prevent or mitigate the onset of substance use/abuse during critical periods.